Defining the role of plasma cells in the establishment of KSHV infection in human tonsil

Abstract/Project Summary
Kaposi sarcoma-associated herpesvirus (KSHV) is an oncogenic human herpesvirus, which causes Kaposi
sarcoma (KS) as well as B cell lymphoproliferative disorders in the absence of adequate immune control. KSHV-
associated tumors are a significant cause of morbidity and mortality in transplant patients and individuals with HIV-
disease. The oral cavity is an important site for KSHV biology because saliva is believed to be the primary mode of
person-to-person transmission for the virus. The tonsil and other oral lymphoid tissues represent a logical
anatomical site for early infection events because they are in contact with saliva and are rich in target cell types for
KSHV infection including endothelial cells and B lymphocytes. Despite this, the biology of KSHV in the human tonsil
remains poorly understood. We have developed an extensive library of human tonsil specimens and a robust ex
vivo infection model KSHV in tonsil-derived lymphocytes. Using these tools, we have recently discovered that
mature plasma cells are highly targeted early in KSHV infection and that KSHV-infected plasma cells display a
mixture of latent and lytic infection cycles. The current proposal will test several hypotheses: (1) plasma cell infection
serves as an amplification step which is important for the overall establishment of infection in tonsil lymphocytes,
(2) the KSHV-encoded cytokine vIL-6 is critical for establishment of KSHV infection in lymphocytes via manipulation
of plasma cell biology and (3) the T cell-derived cellular cytokine IL-21 supports KSHV dissemination by driving
differentiation of plasma cells, and can partially replace the function of vIL-6 in early infection. The results of this
research will provide critical mechanistic details that will enhance our understanding of early events in KSHV
transmission and the establishment of KSHV infection in the lymphocyte compartment.

Public health relevance
Project Narrative Infection with Kaposi Sarcoma-associated Herpesvirus (KSHV), a herpesvirus primarily transmitted via saliva, is conclusively linked to several cancers in the context of immune dysfunction, and despite many years of research, fundamental questions remain about how KSHV is transmitted from person-to-person. In this proposal, we will determine the origin, role and significance of mature antibody-secreting B cells (plasma cells) as targets for early KSHV infection. The mechanisms defined in this study will provide novel insights into KSHV transmission and identify new targets for limiting the ability of the virus to invade the human immune system.